NARCH XIII-Student Development

PROGRAM SUMMARY ABSTRACT- ADMIN CORE
The overall goals of the CA-NARCH Administrative Core are to support the educational and research
efforts of the CA-NARCH Student Development Program and to provide critical ongoing community
based participatory tribal direction. The administrative structure of the CA-NARCH has evolved through
funding from NARCH III, NARCH V, NARCH VII, NARCH X, AND NARCH XI and consists of the
IHC Executive Team; Dan Calac PI, Temet McMichael Program Director, Corinne McDaniels-Davison
Research Director, and the CA-NARCH Tribal IRB. The CA-NARCH CORE supports the center
components to fulfill the overall NARCH mission to implement health research projects prioritized by the
area tribes. The purpose is to reduce mistrust in research among AI/AN, enhance the research capacity
and partnerships and develop a cadre of health research professionals to help reduce AI/AN health
disparities. The CA-NARCH is based at Indian Health Council (IHC), a tribal organization that supports a
consortium of 9-tribes in San Diego County. The CA NARCH XI Administrative Core will help fulfill
the major aims and goals of all Center components by pursuing the following specific aims: 1) To provide
leadership and management, including administrative and fiscal oversight of the CA-NARCH student
development project; 2) To coordinate communication and dissemination of information between the
local tribes, tribal leaders, and the student development program team; 3) To support the cultural interface
and provide ethical research training in the SDP 4) To seek out and disperse information on funding
opportunities through NARCH and other sources for continued development of training and mentoring
programs and/or research projects; 5) To evaluate progress of the CA-NARCH in achieving its objectives
and milestones. The specific aims will support the efforts of the CA-NARCH mission of conducting
highly relevant, American Indian/Alaskan Native (AI/AN) community-based research and establishing a
trained cohort of scientists dedicated to impacting the health disparities of AI/AN populations. Activities
in the CA-NARCH are also evaluated by the CA-NARCH IRB, which is officially registered with the
U.S. DHHS Office of Human Subjects Research Protection (OHRP) as #IRB00004101 and has received
Federal-wide Assurances approval under Indian Health Council, Inc., and is registered as
#FWA00006757. This work shall also strive to establish a replicable model partnership for tribal nations
and academic organizations.

Public health relevance
Program Narrative The CA NARCH XIII Administrative Core will help fulfill the major aims and goals of all Center components by pursuing the following specific aims: 1) To provide leadership and management, including administrative and fiscal oversight of the CA-NARCH student development project; 2) To coordinate communication and dissemination of information between the local tribes, tribal leaders, and the student development program team; 3) To support the cultural interface and provide ethical research training in the SDP 4) To seek out and disperse information on funding opportunities through NARCH and other sources for continued development of training and mentoring programs and/or research projects; 5) To evaluate progress of the CA-NARCH in achieving its objectives and milestones. The specific aims will support the efforts of the CA-NARCH mission of conducting highly relevant, American Indian/Alaskan Native (AI/AN) community-based research and establishing a trained cohort of scientists dedicated to impacting the health disparities of AI/AN populations.